The roles of EBV-specific T cells in response to checkpoint blockade immunotherapy of EBV-driven nasopharyngeal carcinoma

Project Summary/Abstract
Nasopharyngeal carcinoma (NPC) is an Epstein-Barr virus (EBV)-driven malignancy that is endemic to East and
Southeast Asia. The overall 5-year survival rate for endemic NPC is only 51%, which represents an unmet clinical
need. While NPC tumors are known to be infected with EBV and express PD-L1, little is known about the role of
EBV-specific T cells in the control of NPC and anti-PD-1 therapy has shown a low rate of efficacy (ORR ~20%).
The goal of this study is to better understand the role of EBV-specific T cell responses in NPC immunopathology
and immunotherapeutic response. We will test the specific hypotheses that: 1. EBV-specific T cells contribute to
tumor control elicited by combination anti-PD-1 and anti-CTLA-4 checkpoint blockade immunotherapy, and 2.
that the phenotypic and clonal characteristics/dynamics of peripheral EBV-specific T cells can be useful as
indicators of clinical outcomes for NPC patients. To test these hypotheses, we will leverage our access to two
Singaporean NPC patient cohorts: Cohort 1. A 51-patient cohort of new-diagnosis NPC for which viably frozen
PBMCs and archival FFPE tissues are available and Cohort 2. A 50-patient cohort participating in a phase II
trial (NCT03097939 - National Cancer Centre Singapore) testing the combination of Ipilumimab and
Nivolumimab (Ipi.+Nivo.) immunotherapy with longitudinally collected PBMCs and tissue biopsies. Recently
published preliminary analysis (AACR 2020) from this clinical trial shows that combined Ipi.+Nivo. therapy is safe
and achieved durable responses in recurrent and metastatic NPC patients and identified a negative association
between circulating EBV-DNA levels and response. In addition, preliminary analysis of new-diagnosis NPC
patient peripheral blood samples from Cohort 1 show associations between certain phenotypic profiles of CD8+
T cells and clinical parameters such as EBV-DNA levels. Therefore, in Aim 1. we will investigate the clinical
relevance of these preliminarily identified NPC-associated CD8+ T cell phenotypes. In addition to in-depth single
cell transcriptional, functional TCR sequence profiling of these cells, cellular imaging, transcriptional profiling and
bulk TCR sequencing of patient-matched tumor will allow discovery of novel associations between peripheral T
cells and the tumor microenvironment. In Aim 2., we will characterize EBV-specific T cell responses in the NPC
periphery and tumor microenvironment during combination Ipi.+Nivo. immunotherapy treatment to identify novel
associations between the phenotypic profiles of EBV-specific T cells and immunotherapeutic response. In Aim
3., we will investigate T cell clonal dynamics associated with treatment induced changes to the NPC-specific
immune response by comparing the TCR clonal diversity in peripheral blood and tumor biopsy samples from
different stages of treatment. Overall, characterization of EBV-specific T cells phenotypes in the NPC periphery
and the tumor using multiple cutting-edge approaches will not only improve our understanding of the NPC
immune landscape, but also potentially identify clinically relevant EBV-specific T cell phenotypes that could be
tested in future NPC immunotherapy trials.

Public health relevance
Project Narrative Nasopharyngeal Carcinoma (NPC) is a common form of head and neck cancer that is driven by Epstein Barr Virus (EBV) and especially prevalent in South East Asia at a rate of 15-50 cases per 100,000 people per year. In this project, we will study two NPC cohorts, a 51-participant new-diagnosis cohort and a 50-participant longitudinally sampled Phase II clinical trial cohort treated with the combination of anti-PD-1+anti-CTLA-4 (Ipilimumab+Nivolimumab) checkpoint blockade immunotherapy (cICI). With the goal better understanding the role of peripheral EBV-specific and other NPC-associated T cell responses in nasopharyngeal carcinoma (NPC) immunopathology, we will use a variety of single analysis methods applied to blood and tumor tissue to test the hypotheses that EBV-specific T cells contribute to tumor control elicited by cICI and that the phenotypic and clonal characteristics/dynamics of peripheral EBV-specific T cells can be useful as indicators of clinical outcomes for NPC patients.